R38 Stanford Integrated Cardiovascular/Pulmonary Residency Research Training Program

PROJECT SUMMARY
Stanford University School of Medicine is a site of unparalleled excellence in biomedical research and is a
innovative leader in the fields of cardiovascular and pulmonary medicine. The Stanford Integrated
Cardiovascular/Pulmonary Residency Research Training Program described in this proposal will provide
research opportunities for talented individuals engaged in the residency stage of their medical training. The
program will draw resident investigators from the Stanford residency programs in Internal Medicine, Pediatrics,
Cardiothoracic Surgery, and Radiology, and place them in basic, translational, and clinical research laboratories
affiliated with the Stanford Cardiovascular Institute (CVI) for a mentored research experience lasting 1-2
years. Upon completion of their clinical training, successful resident-investigators would be eligible for K38
funding to support continued research efforts. This program would also fill a particular need of the Cardiothoracic
Surgery and Anesthesiology residency programs, which require their trainees to dedicate a period of their time
to research and would provide new and valuable opportunities for residents in other specialties. Research
mentors for the proposed StARR program would be members of the Stanford CVI, which offers a unique platform
by which to train the next generation of basic and translational scientists. Major research programs within the
CVI are organized into Cardiac, Vascular, and Pulmonary disease categories, incorporating the disciplines of
Genomics, Proteomics and Bioinformatics; Cellular and Molecular Biology; Imaging; Bioengineering; and
Population Science. CVI scientists share a common interest in the mechanisms behind cardiovascular and
pulmonary medicine, and work together towards creating novel therapeutic, regenerative, and preventative
approaches to cardiovascular and pulmonary diseases. Furthermore, the CVI already offers multifaceted
educational and career development programs that would enhance the experience of StARR trainees and
prepare them to launch successful careers as future clinician scientists with successful academic careers.

Public health relevance
PROJECT NARRATIVE Cardiovascular and pulmonary diseases are the leading causes of death in the United States, claiming over a million lives each year and exerting an undue financial toll. There is an ongoing unmet need to develop a cohort of clinician scientists who can combine their rigorous clinical training with research initiatives to pioneer new approaches and innovations for cardiovascular and pulmonary disease therapy and prevention strategies. The proposed R38 StARR grant will provide mentored training opportunities for medical residents in laboratories at Stanford University School of Medicine focused on Cardiovascular and Pulmonary Health, promoting their pursuit of the clinician-scientist career path.